Leadership Administrative Core

LEADERSHIP ADMINISTRATIVE CORE: SUMMARY/ABSTRACT Michelle M. Mielke, Ph.D.
The overall objective of the Leadership and Administrative Core (LAC) of the Mayo Clinic Specialized Center
of Research Excellence (SCORE) on Sex Differences is to provide centralized, efficient mechanisms by which
the scientific and educational programs can be monitored, evaluated, and continuously improved. To achieve
this objective, a set of practices are established to assure that all aspects of the SCORE are administered
efficiently and fairly, and that the overall project encourages innovation and career development of the next
generation of researchers in women's health and sex differences. Drs. Mielke and Miller, the Co-Principal
Investigators for this SCORE, will serve as Co-Directors along with Dr. Rocca, Associate Director. They are
responsible for planning, reviewing, coordinating, and directing the SCORE through regular meetings of the
SCORE Investigators and the internal and external advisory groups. Decisions regarding allocation of
resources, prioritization of goals, and changes in direction of the program will be made by Dr. Mielke based on
input from these advisory groups. An Executive Committee, consisting of all the Principal Investigators of the
projects and cores, will select candidates for the Career Enhancement Awards and the Research Stimulus
Awards developed through the Career Enhancement Core that is designed to assure viability of the Center for
the next generation of investigators in sex-differences research. The LAC has developed a plan for the
financial management of the SCORE, for conflict resolution, and for communicating and disseminating our
ongoing research findings and resources to the broader clinical and research community. The network
established among the SCORE investigators nationwide and their external connections with other professional
groups focused on women's health and sex differences assures that the Mayo Clinic SCORE fulfills the intent
and objective for which the program was created.

Public health relevance
LEADERSHIP ADMINISTRATIVE CORE: PROJECT NARRATIVE Michelle M. Mielke, Ph.D. The Leadership and Administrative Core (LAC) of the Mayo Clinic Specialized Center of Research Excellence (SCORE) on Sex Differences will provide centralized, efficient mechanisms to monitor, evaluate, and continuously improve the scientific and educational programs. Additionally, the LAC will assure viability of the Center for the next generation of investigators in sex-differences research. Lastly, the LAC will actively participate in the annual SCORE Directors' Meeting and will provide intellectual leadership in support of the activities of the SCORE consortium.